Flow Cytometry Shared Service

16.0 Abstract: Flow Cytometry Shared Service
The Flow Cytometry Shared Service (FCSS) provides investigators at the University of Maryland Marlene and
Stewart Greenebaum Comprehensive Cancer Center (UMGCCC) with essential services that support research
in immunology and cancer biology requiring flow cytometry and with analytical (spectral and mass cytometry)
and cell sorting capabilities. FCSS provides convenient access to cost-effective and high-quality services
managed by expert staff. FCSS was the first facility in the Baltimore/Washington area with both mass and
spectral cytometry instrumentation. The two Helios mass cytometers enable simultaneous measurement of
large numbers of parameters (currently >50 parameters/cell) with minimum compensation. Using the new-
generation Cytek Aurora spectral cytometers, FCSS has developed in-house 23- and 30-color
immunophenotyping plug-and-play use panels. The MoFlo Astrios advanced cell sorter provides the ability to
simultaneously sort six populations under BSL-2 containment. A Miltenyi MACSQuant Analyzer 10 is housed in
this space which is only accessible to FCSS staff and is used to analyze clinical samples for CAR-T cell therapy
developed in our Fannie Angelos GMP Laboratory for Cellular Therapeutics. These state-of-the-art
instruments offer innovative approaches to study immunology and cancer biology and to monitor novel
clinical trials. FCSS is staffed by technical experts with decades of experience in the operation of flow
cytometers/sorters and mass cytometers. The monthly lectures presented by the FCSS director are attended by
nearby members of academic institutions, hospitals, and biotech companies, and the lectures are widely
considered a great educational resource. An internal scientific advisory board consisting of FCSS users provides
guidance to FCSS and helps develop strategic planning for new equipment and technologies. FCSS provides
easy access to flow cytometry services. Cancer Center investigators with peer-reviewed funding are prioritized.
FCSS services are highly cost-effective, as the fee structure is competitive with other academic and commercial
sources, and a 25% UMGCCC-funded subsidy is given to Cancer Center members. FCSS is highly utilized. In
2019, FCSS supported studies by 90 total investigators, 42 (46.7%) of whom were UMGCCC members. FCSS
supported $62.4 million of total funding. $27.3 million of this funding was cancer-related, all of which was peer
reviewed. FCSS supported 213 cancer-related publications from 2015 to 2019, including those published in such
high-impact journals as PNAS, Nature, and Nature Communications.